The Last Mile of Interoperability: Integrating Outside Data Into Clinical Workflows to Improve Care

PROJECT SUMMARY
Building a nationally interoperable health care delivery system remains a top priority in US health care, with
early studies theorizing that robust data exchange could reduce health care costs by over $80 billion annually.
Despite recent efforts to enhance interoperable health information exchange, there is mixed or insufficient
evidence that increased connectivity between health care delivery organizations is improving outcomes or
reducing costs. One potential reason for this is the “last mile” of interoperability; busy clinicians lack the time to
search for, view, and process patient data delivered via interoperability, which is often not integrated into the
local electronic health record (EHR). Delivering on the promise of interoperability requires a better
understanding how clinicians use data generated outside their institution, and the value of that data for
improving outcomes such as utilization, quality, and patient satisfaction. Finally, developing actionable
guidelines for when and where outside records data (ORD) is valuable within the context of a given encounter
is critical to building interoperability solutions that facilitate high-value use by clinicians.
To address this, our study – The Last Mile of Interoperability: Integrating Outside Data Into Clinical Workflows
to Improve Care – will leverage a natural experiment and detailed EHR metadata from two institutions to
identify the causal impact of HIE use on a range of patient outcomes including costs and utilization, health, and
patient satisfaction. We will use an innovative combination of robust econometric instrumental variables to
identify the impact of ORD review and novel machine learning methods to reveal the clinical scenarios where
HIE use is likely to be valuable within the context of a specific clinical encounter. We will use these results to
generate public goods that will guide the development and evaluation of tools designed to streamline clinician
information consumption and optimize the review of outside records data with a focus on new artificial
intelligence and large language model applications. Our study will generate actionable evidence on the impact
of outside record integration, the value of viewing outside records data by clinicians, and inform the
development and evaluation of new technologies towards the goal of realizing the benefits of the national
investment in interoperability.

Public health relevance
PROJECT NARRATIVE Seamless data interoperability holds immense promise to drive down health care costs, reduce utilization, and improve health outcomes and patient satisfaction, however, evidence on the impact of interoperability has been mixed. Our study will investigate this by using novel electronic health record (EHR) metadata that directly observes when clinicians view outside records data (ORD) generated from institutions outside their own and a robust analytic approach that combines causal inference econometrics with new machine learning methods, we will identify the value of ORD review across a range of utilization, quality, and patient satisfaction outcomes, and assess variation in that impact across clinical scenarios. We will then produce several open-source public goods in the form of computable clinical phenotypes and a prompt engineering framework to guide the development and evaluation of new artificial intelligence tools seeking to streamline how clinicians consume information from the EHR.